The development of the Clinical Picture Maker, a novel video platform to aid the diagnosis and treatment of SCN2A-related disorders, and other rare diseases.

ABSTRACT
This STTR application proposes a new platform, the Clinical Picture Maker, which aims to facilitate the
production, organization, and dissemination of video documentation that can improve the diagnosis and
treatment of rare and difficult to diagnose disorders. At present, people with rare disorders and their caregivers
often face a 5+ year search for a diagnosis, which can lead to serious complications and suffering. There are
more than 10,000 identified rare diseases. Clinicians are unfamiliar with most of them and therefore have
difficulty recognizing the symptoms. Text descriptions are available but do not fully convey the visual signs and
complexities. For nearly 3 decades, GeneticaLens (GL) has produced video databases and tools to help solve
these problems. With SBIR awards on Angelman Syndrome and autism, GL developed a system of filming,
editing, validating and disseminating video segments and screening tools, which has helped healthcare
professionals recognize these disorders and provide appropriate care. This project makes it possible to scale
the system, so that more rare disorders can benefit from video through the creation of the Clinical Picture
Maker, a streamlined set of tools for producing video documentation of rare diseases. They include: 1) the
DAYTool, a web app that teaches people with rare disorders and their caregivers to use their smartphones to
record and upload videos of symptoms and daily life and 2) the Rare Disorder Video Lexicon (Lexicon), a
searchable, ever-expanding collection of videos uploaded using the DAYTool. In Phase I, GL, in partnership
with New York University, will test the use of the Clinical Picture Maker with a group of parents whose children
have rare developmental disorders related to variations in the SCN2A gene. These disorders cause severe
seizures, movement disorders, autonomic dysfunction and autism. A group of parents of children with the
SCN2A will use the DAYTool to film their children and upload the video to the Clinical Picture Maker database.
With guidance from GL and SCN2A experts, NYU graduate film students will edit the video, add key words and
expert interviews, and organize the video into the Lexicon. GL will then evaluate whether the videos uploaded
using the DAYTool will be effective in helping a group of clinicians and residents at NYU’s medical school learn
to recognize and distinguish between the key symptoms of SCN2A-related disorders. Average number of
correctly identified symptoms between a group of clinicians viewing educational videos and a group viewing
only text, will be contrasted using a two-sample t test. With groups of twenty participants, we will have 0.80
power to detect Cohen’s d of 0.91, corresponding to a large effect size. In Phase II, GL will include other rare
neurodevelopmental disorders that cause similar symptoms, creating a comprehensive resource on this group
of disorders and the first iteration of the Lexicon. The long-term goal is widespread use of the DAYTool for
patients and parents to communicate with clinicians and researchers as well as a more complete Lexicon
available by subscription to clinics and medical schools.

Public health relevance
PROJECT NARRATIVE Individually, each of the 10,000+ identified rare diseases affects fewer than 200,000 people; cumulatively, rare disorders impact over 25 million Americans and 400 million people worldwide. Clinicians lack experience and training in rare diseases, rarely see patients with rare diseases, and thus often fail to recognize the symptoms, and as a result, people with rare disorders and their caregivers can face an harrowing search for a diagnosis that lasts six to eight years. GeneticaLens and New York University partners are focused on developing the Clinical Picture Maker, a software platform that will create video documentation of rare diseases on a worldwide basis by inviting parents, caregivers and patients themselves to log on and create video of their daily lives, making it possible to develop an extensive database of videos of multiple rare disorders to improve medical training, diagnosis and treatment.